Novel Immunogens to Elicit Broadly Cross-reactive Antibodies That Target the Hemagglutinin Head Trimer Interface

Abstract
Novel vaccines are needed that have higher efficacy and that provide long-lasting protection against emerging
influenza viruses. An attractive approach towards developing a “universal” vaccine is focused on eliciting
antibodies that target conserved regions of the hemagglutinin (HA) protein on the surface of the virus. The
receptor binding site and the stem are two such HA regions, and the elicitation of humoral responses focused
on these sites has been the subject of multiple studies. Recently, a new class of antibodies has been
discovered that targets the highly conserved HA head trimer interface. Antibodies against this epitope were
found in multiple individuals, have broad heterosubtypic cross-reactivity and provided protection against viral
challenges in animal models. Therefore, induction of these type of antibodies as part of a universal influenza
vaccine would be valuable. The head trimer interface epitope is occluded in crystal structures of HAs, and
likely becomes exposed just transiently through molecular “breathing”. This limited accessibility may explain at
least in part why natural humoral responses against this site are rare. In this proposal, we will engineer
immunogens that present unobstructed the HA head trimer interface epitope in molecular contexts devoid of
other immunodominant sites. Using computational protein modeling and high throughput library screening, HA
derived as well as non-influenza based immunogens will be developed that: 1) expose the HA head trimer
interface to facilitate immune recognition; 2) preferentially interact with broadly cross-reactive, but not with
strain specific, antibodies that target this site and 3) occlude immunodominant regions to focus the immune
responses on the epitope. Designed immunogens will be used to vaccinate small animals to assess their ability
to protect against live virus. Detailed analysis of the B cell receptor repertoires of vaccinated animals will reveal
the developmental pathways that lead to the activation and maturation of humoral responses against the
conserved HA head trimer interface. This proposal will provide candidate immunogen towards the development
of a universal influenza vaccine, lead to a better understanding of molecular features that control HA
conformation and immunogenicity, and establish general approaches for immunogen design.

Public health relevance
PROJECT NARATIVE This research is focused on eliciting a novel class of antibodies that can prevent infections by the majority of influenza strains. Immunization regimens developed and validated in this proposal could provide universal protection against influenza viruses by vaccination. Thus, the proposed research is relevant to part of the NIH’s mission that pertains to protecting and improving health by preventing disease.